Genetically Encoded Probes of Huntingtin Misfolding

Abstract
Huntington’s disease is caused by polyglutamine expansions in the huntingtin protein. These polyQ
expansions make the huntingtin protein, and its naturally occurring exon1 fragment (Httex1), more aggregation
prone. Deposition of fibrillar Httex1 aggregates in the brain is a hallmark of the disease in patients and animal
models. We have shown that Httex1 aggregation is a step-wise process wherein Httex1 gives rise to different
misfolded species prior to formation of fibrils. Early species in the misfolding pathway are of particular interest
as they can cause the formation of seeds, which cause further misfolding of monomeric Httex1. This process not
only enhances toxicity in a given cell, but it can also cause spreading of misfolding throughout the brain. In
addition, earlier misfolding intermediates could also directly contribute to disease, as their toxicity has been
observed in cell culture experiments. Despite their importance, early misfolding intermediates cannot easily be
detected in biological tissues and it has not been possible to interfere with their seeding ability or toxicity. In this
project, we aim to address these fundamental problems by developing genetically encoded ligands (peptides)
that bind early misfolding intermediates and by testing their potential biomarker or therapeutic utility.
To accomplish these goals, we have assembled a team of three PIs with expertise in peptide ligand discovery
(Roberts), huntingtin protein structure and function (Langen), and cell-based and animal-based disease models
(Chen). The Langen lab has laid the biochemical foundation for the proposal by identifying and characterizing
different forms of Httex1 aggregates. Working together, the Roberts lab has used directed evolution and mRNA
display to generate Httex1 directed (HD) peptide ligands against protofibrils. The Langen and Chen lab have
demonstrated that HD peptides inhibit Httex1 misfolding in vitro and in cultured cells. Importantly, HD peptides
also protect from Httex1 toxicity in cultured cells. In Aim 1, we propose to extend this work by characterizing the
interactions of HD peptides with protofibrils using biophysical methods. Specifically, we will determine the HD
peptide’s affinity, specificity, molecular mechanism of interaction with protofibrils and we will evaluate their ability
to inhibit misfolding. Moreover, we will use peptide multimerization and other optimizations to achieve ultra-high
affinity binding. Aim 2 then uses these well characterized binders in animal and cell models to evaluate their
utility as biomarkers and therapeutics in cell cultures and animal models. In aim 3, we will generate binders for
the earliest misfolding intermediate, the a-helical oligomers, and test our prediction that binders to these species
block the formation of seeds and protect from Httex1 misfolding and toxicity.

Public health relevance
Project Narrative: The aggregation of the huntingtin protein plays an important role in Huntington’s Disease. This proposal examines trillions of peptides to find rare molecules that can bind these huntingtin protein aggregates, but not the rest of the cell’s components, thereby rescuing normal cellular function. These peptides are designed to have biomarker and therapeutic potential and the same approach used here can also be applied to other age-related neurodegenerative diseases, such Alzheimer’s and Parkinson’s Disease.